Mapping Cortical Area Organization in Healthy Adults Using High-Resolution HCP Data: Insights into Human Brain Function and Morphology

Project Summary/Abstract
The outer layer of the mammalian brain, the cerebral cortex, contains a mosaic of functionally and anatomically
distinct areas. Understanding the organization and individual variability of these cortical areas is fundamental for
decoding the unique brain function (i.e., individual differences in cognition, behavior, personality, psychiatric
symptoms, substance use, susceptibility to brain disorders, etc.) and the heritability of these variations. High-
resolution structural and functional magnetic resonance imaging data from 1071 healthy young adults aged 22-
35 years (485 males and 586 females, including monozygotic and dyzgotic twins, non-twin siblings, and
unrelated individuals) provided by the Human Connectome Project (HCP) have revealed a group-average map
of 180 cortical areas per hemisphere. Recent methodological advances have led to the generation of individual
subject cortical area parcellations that show significant differences from the group average map. The proposed
work focuses on understanding individual variability in human cortical areal organization, estimating the
heritability of this variability, and identifying its behavioral correlates. To achieve such understanding, Aim 1 of
this proposal will investigate cortical areas in terms of their size, scaling, shape, topology, and number, also
testing the bilateral symmetry across the left and right hemispheres. The reproducibility of novel findings will be
evaluated by the HCP test-retest dataset consisting of 205 young adults scanned twice at 3T or 7T. Aim 2 will
estimate the heritability of the variations identified in Aim 1 by disentangling the genetic and environmental
contributions using the twin-pair HCP data. Finally, Aim 3 will examine the relationship between individual
variability in cortical organization and and individual behavioral measures from the HCP Individual Behavioral
Assessment dataset. The expected outcomes of the proposed work include i) exploration of individual cortical
area variability by developing measurable, quantitative, imaging-based metrics that objectively and reproducibly
determine individual variability, ii) investigation of the reproducible existence and prevalence of atypical areal
topologies, iii) determination of the reproducible prevalence of missing or extra areas among individuals, iv)
estimation of the heritability of individual cortical area variability, and v) relation of individual cortical area
variability to differences in individual behavior. The broad, long-term objective of this proposal is to map the
brain-behavior relationship among individuals, while elucidating the genetic and environmental influences on this
mapping, to better understand mental function and dysfunction that lead to adaptive and maladaptive behaviors,
and to inform personalized approaches to diagnosis, treatment, and prevention of mental illnesses. The
proposed work and the training plan will be conducted in the Glasser and Van Essen lab at Washington University
in St. Louis and will prepare the applicant to become a successful independent researcher studying the
organization of the brain in health and disease.

Public health relevance
Project Narrative The proposed research will advance fundamental knowledge of individual variability in cortical organization, particularly with respect to the size, shape, topology, and total number of cortical areas in healthy young adults. The study will provide critical insights by estimating the heritability of these variations and their associations with behavioral profiles and cognitive abilities. In the long term, these findings may inform public health initiatives by mapping brain-behavior relationships and identifying biomarkers of mental health, ultimately enhancing the well- being and health outcomes of individuals and communities.